Image-guided dosimetry-based alpha particle therapy for neuroblastoma.

SIGNIFICANCE: Neuroblastoma is the most common pediatric cancer, accounting for 15% of cancer deaths,
with a 5-yr survival of <40% due to resistant metastases. Neuroblastoma tumors almost universally express the
somatostatin receptor 2 (SSTR2) and high expression has been shown clinically using peptides targeting SSTR2
(PMID10706954). FDA approved SSTR2-targeted beta(β-)-emitting 177Lu-labeled Lutathera™ has been shown to
be safe and feasible (PMID21680680), but tumor response to SSTR2-targeted β--therapy has been poor. On the
other hand, Viewpoint’s next-generation SSTR2-targeted [212Pb]VMT-α-NET alpha(α)-particle therapy (α-PRRT)
produced complete responses (CRs) in 70% of mice bearing SSTR2+ tumors. Data show that the significantly
improved PK properties of VMT-α-NET compared to competing SSTR2 targeted radiopharmaceuticals leads to
significantly improved tumor to normal accumulation and lower risk of toxicities (particularly in dose limiting kidneys). In
the revised application, the team introduces an innovative immune-competent genetically engineered metastatic
mouse model (GEMM) of neuroblastoma (new Co-Investigator Wang PhD at Nationwide Children’s Hospital) that
genetically mimics neuroblastoma in humans and develops spontaneously in mice. Thus, we will identify effective
regimens and assess potential toxicities (e.g., kidney) and inflammatory markers in preparation for FDA submissions.
The revised project is significant because predicate data demonstrate that Viewpoint’s [212Pb]VMT-α-NET α-PRRT has the potential to provide for complete/durable tumor responses (and be well tolerated) for neuroblastoma
patients. The project is further significant because the GEMM rodent model and CMC plan included is aligned
with FDA guidance for micro-dosed radiopharmaceutical therapeutics and our communications with the FDA for
Fast Track designation. Therefore, there is a critical need to advance Viewpoint’s α-PRRT to clinical trials for
neuroblastoma patients for whom other therapies (including SSTR2 β-particle therapy) fall short.
PREDICATE MILESTONES: $13M Series A; 70% CRs in mice; 203Pb/212Pb secured; Communications with FDA
to secure two INDs and complete a pre-IND meeting with support from the FDA for α-particle therapy for adult
trials. FDA communications are ongoing. We will achieve our objectives by completing these Specific Aims.
AIM 1. Determine the dosing regimens of [203Pb]VMT-α-NET image-guided [212Pb]VMT-α-NET therapy that
maximize complete responses and minimize toxicity in mouse models of metastatic neuroblastoma.
AIM 2. Optimize [212Pb]VMT-α-NET production and complete technology transfer for CMC and IND
submission to the US FDA to initiate a Phase 1 imaging-guided therapy trial in neuroblastoma patients.
IMPACT: With completion of these Aims, we expect to have developed a detailed understanding of the
therapeutic regimens that maximize tumor responses (minimizing toxicity) in metastatic models of neuroblastoma
in mice that align with FDA guidance for a Fast Track application. We further expect to complete formulation and
CMC documentation for the submission of an IND for Phase 1 trials of Viewpoint’s TAT for neuroblastoma.

Public health relevance
This proposal is aims to develop an alpha-particle radionuclide therapy for neuroblastoma that improves tumor responses, while minimizing toxicities. No other agents are available that are based on this approach.